Community Health and Aging in Native Groups of Elders Resource Center for Minority Aging Research (CHANGE RCMAR)

OVERALL ABSTRACT
The Community Health and Aging in Native Groups of Elders (CHANGE) Resource Center for Minority Aging
Research (RCMAR) is a new iteration of the Native Elder Research Center (NERC) that has been continually
funded since its inception in 1998. CHANGE will relocate the RCMAR to Washington State University’s Institute
for Research and Education to Advance Community Health and continue to increase the diversity of
investigators conducting research with Native populations in the US, defined here as American Indian,
Alaska Native, and Native Hawaiian, and Pacific Islander people. We maintain an 18-month cycle, draw on long-
established best practices, offer innovative solutions to improvements identified by former NERC Faculty and
Scientists, integrate a community-based approach, and expand our diversity, equity, inclusion, and accessibility
platform to create a culture of inclusiveness and support for 9 diverse early-career faculty (3 per cycle). CHANGE
is led by MPIs Dedra Buchwald, MD, at Washington State University, and Julie Baldwin, PhD (Cherokee
Nation of Oklahoma), at Northern Arizona University; they will co-lead the Leadership and Administrative Core.
The Research Education Component will be led by Clemma Muller, PhD, MS, at Washington State University;
and the Analysis Core will be led by Richard MacLehose, PhD, at University of Minnesota. Gary Ferguson,
ND (Unangax̂/Aleut), at Washington State University, will lead Community Integration activities to embed
community engagement and education into the Pilot Studies and all aspects of CHANGE, upholding our
commitment to principles of participatory research. We feature subcontract affiliations with Mentors Valarie
Jernigan, PhD (Choctaw), a former NERC Faculty and Scientist, at Oklahoma State University; Scott
Okamoto, PhD, a current RCMAR Mentor, at University of Hawai’i at Mānoa; and Mandy Fretts, PhD (Eel
Ground First Nation), at University of Washington. Our Specific Aims are to: 1) Deliver the 18-month CHANGE
curriculum to a diverse cohort of 9 Scientists pursuing careers in aging research with Native people; 2) Provide
state-of-the-art support for CHANGE Scientists’ Pilot Studies within a holistic framework of mentoring,
professional development, and research excellence; 3) Integrate CHANGE Scientists into a network of
investigators, RCMAR alumni, and community partners who conduct Native health research and promote Native
health interventions; and 4) Embed principles of community outreach, engagement, and participatory research,
as well as diversity, equity, inclusion, and accessibility across all CHANGE activities. The literature on training
programs for underrepresented minority investigators highlights the success of personalized, culturally-informed
training and access to underrepresented minority role models. CHANGE is highly responsive to RFA-AG-23-
026’s requirements of recruiting Scientists and providing Mentors from the parent or affiliated institutions, while
concurrently accommodating the real-world limitations presented by the highly-dispersed and relatively-small
community of early-stage investigators and senior faculty conducting aging-related research on Native health.

Public health relevance
PROJECT NARRATIVE Racial and ethnic minorities – especially American Indians, Alaska Natives, Native Hawaiians, and Pacific Islanders – are underrepresented in health research. The Community Health and Aging in Native Groups of Elders Resource Center for Minority Aging Research is training program that focuses on community-based research with Native communities. It will also implement the National Institute on Aging’s mandate to increase the diversity of investigators conducting research with Native populations in the US.